Hunting the HIV-1 Unicorn

Project Summary While there are many public health strategies in place for reducing HIV-­1 infection rates in drug users, an effective HIV-­1 vaccine remains critical to this effort. Studies of HIV-­1 transmission, pathogenesis, and vaccine development are mostly conducted in macaque monkeys, although this primate model of HIV-­1 infection has many limitations. In the decades since the macaque model was established, we have learned a tremendous amount about the immune response against HIV-­1 and SIV. However, this hard-­earned knowledge has never been synthesized into an integrated, rational approach for re-­evaluating and optimizing the nonhuman primate model for HIV-­1 infection. By the end of this proposed project we will have HIV-­1, or a very minimally engineered form, replicating in monkeys. To accomplish this goal, we present a principled approach capitalizing on the enormous knowledge base in the field, and on the substantial genetic diversity present in animals held captive in primate research centers. We will genotype restriction factor alleles from thousands of nonhuman primates representing several key primate species (rhesus macaques, pigtailed macaques, owl monkeys, baboons, marmosets, and squirrel monkeys) and test all discovered restriction factor alleles against HIV-­1. Each discovered allele will be given an HIV-­compatibility score, allowing systematic and rational determination of which species, and which specific individuals within those species, have restriction factor genotypes that will require minimal modification of HIV-­1. As part of our approach, we will also evaluate MHC, KIR, and antibody receptor (FcR) gene content and allelic diversity in these primate species. We will specifically optimize this model for infection with transmitted/founder (T/F) HIV-­1, the variants that an effective vaccine needs to recognize. We will consider T/F viruses after both sexual and intravenous infection, the two main modes by which drug users acquire HIV-­1 infection. A model of persistent HIV-­1 infection in monkeys will open up exciting new avenues in the study of HIV-­1 pathogenesis and transmission, and in the development of drugs and vaccines.

Public health relevance
Project Narrative In the decades since the macaque model for HIV- 1 was established, we have learned a tremendous amount about the immune response against HIV- 1 and SIV. We synthesize this information into an integrated, rational approach for optimizing the nonhuman primate model for HIV- 1 vaccine development. If host barriers can be minimized and HIV- 1 itself can be studied rather than SHIVs, this will transform research on sexual and needle transmission of HIV- 1 to drug users.